Hazardous Waste Worker Training Program

Atlantic Center for Occupational Health and Safety Training
HWWTP Abstract
The Atlantic Center for Occupational Health and Safety Training has a long history of effective training that meets the
requirements of OSHA 29CFR1910.120, providing hazardous materials knowledge and skills to over 506,000 workers since
1987. Our Center will train workers about safety issues during clean-up of hazardous waste sites, issues related to generation,
treatment and storage of hazardous materials, and emergency response. The courses develop competency in workers to
critically analyze dangerous situations, and enable them to identify safe work practices. Key principles of adult education are
incorporated into our training, and training courses are developed to include peer-learning, hands-on activities, and
development critical thinking skills. The Center has a robust evaluation plan, and will continue to expand the types of data
collected on the impact of training on workplace practice, as well as how training can more effectively influence workplace
safety culture. Our Center proposes to expand our capacity to reach underserved groups throughout Region 2 by adding The
City College at the City University (CCNY) and The Work Environment Council of New Jersey (NJWEC).
The focus of the HWWTP is to provide comprehensive training for workers who clean-up hazardous waste sites, are involved
in the generation, treatment and storage of hazardous materials, and respond to transportation and other emergencies. The
Center will increase access to training in the appropriate language and literacy level for underserved workers and communities.
Over the next five years, the Center proposes to train 26,380 workers in 1,835 courses, providing 387,640 contact hours of
training in the HWWTP.